Estimating the Effects of Medicare Advantage on the Health of Aging Population in Nursing Homes

Older adults aged 65 or older, eligible for Medicare, must choose between traditional Fee-For-Service
Medicare or Medicare Advantage (MA). MA has grown rapidly, covering 54% of Medicare beneficiaries in
2024. This growth has extended to nursing home (NH) residents, where about 23% of those turning 65 require
NH care. In 2021, over 70% of NH residents were long-stay (LS), with the share of MA-enrolled LS residents
rising from 13.3% in 2011 to 31.5% in 2021. To address the needs of LS residents, new care models such as
Institutional Special Needs Plans (I-SNPs) have expanded. Despite the increase of MA and these new models
in LTC, their impact on LS residents in NHs remains understudied. My F99 projects address this gap by
describing MA trends and assessing MA’s effects on NH care quality and health outcomes among LS residents
using rigorous causal methods. My K00 projects will expand the work using the unique NH electronic medical
records (EMR) and newly developed AI algorithms to capture comprehensive health outcomes.
While Medicare doesn’t pay for long-term custodial care in NHs, it covers all other healthcare, like hospital,
post-acute, and hospice care. This incentivizes MA plans to manage care for LS residents. This may help
reduce wasteful care, but it may also limit LS residents’ access to necessary care, making the impacts of MA
on their welfare and health unclear. LS residents, with high levels of chronic illness and limited ability to
advocate for care, are particularly vulnerable to delays or denials of care under MA plans. Aim 1 (F99) will
study the growth of MA and I-SNPs among LS residents and identify determinants of this growth (Aim 1a), and
examine MA’s impact on NH care quality and health outcomes using novel causal methods, including shift-
share instrumental variable (SSIV) and generalized synthetic controls (GSC), which have not yet been used in
aging research (Aim 1b).
Traditional analyses use Claims or the Minimum Data Set (MDS) to assess health outcomes of NH
residents, but the MDS may underreport the outcomes. Aim 2 (K00) will develop natural language processing
(NLP) models to analyze NH EMR, which is the largest nationwide databases, to identify health outcomes like
cognitive and physical functioning, and to uncover details of managed care process among MA-enrolled LS
residents (Aim 2a). Using the most comprehensive outcomes identified by the full administrative data and the
largest NH EMR, I will reevaluate the effects of MA on the health of LS residents, applying GSC (Aim 2b).
My research aligns with the NIA’s goal to understand the factors affecting the health and wellbeing of older
populations, while promoting inclusion of underrepresented groups in aging research. With extensive training
under the mentorship from Dr. Mor (aging research), Dr. Meyers (MA; Health Economist), Dr. Rahman
(Economist), and Dr. Mehrotra (NLP), I will gain the expertise needed to become an impactful faculty
researcher focused on aging, advancing research that addresses critical gaps in the care of aging populations.

Public health relevance
Nearly a quarter of those turning 65 are expected to need nursing home care, and 70% of nursing home residents are long-stay residents who are medically complex, require frequent medical services, and have limited ability to request needed care, making them the frailest population in the healthcare system. While older adults eligible for Medicare, including long-stay residents, must choose between traditional fee-for-service Medicare or Medicare Advantage (MA), which proactively manages care, the impact of MA on long-stay residents remains understudied, despite its rapid growth in this population. In response to the NIA’s goal to understand the factors affecting the health of underrepresented groups in aging research, this proposal will examine the effects of MA on nursing home quality and health outcomes for long-stay residents using rigorous causal methods, and develop a machine learning algorithm analyzing the largest nursing home electronic medical records in the U.S to improve outcome identification, combined with the administrative data.